Novel Systemic Delivery of Peptide-Mediated Anti-Sense Oligonucleotides for Dementia with Lewy Bodies

PROJECT SUMMARY/ABSTRACT
Neurodegenerative disorders of the aging population are characterized by the progressive accumulation of
proteins such as α-synuclein (α-syn), amyloid beta (Aß) and microtubule associate protein (tau). Misfolded and
aggregated α-syn has been implicated in neurological disorders with Parkinsonism including Dementia with
Lewy Body, Parkinson’s disease (PD), and Multiple Systems Atrophy. Accumulation of α-syn has even been
confirmed in over 50% of Alzheimer’s disease (AD). Recent evidence points to a role of α-syn accumulation in
the aggregation of tau and Aß in AD. Thus, regulation of α-syn expression may be crucial to the therapeutic
control of numerous neurodegenerative diseases. Short interfering RNA molecules (siRNA) can bind
specifically to target RNAs and deliver them for degradation; however, RNA molecules do not cross the blood-
brain barrier so the only method for delivery is repeat intra-thecal injections. We recently developed a peptide
(ApoB11) that binds oligonucleotides for transport across the blood-brain barrier following systemic
administration. Using this peptide, we showed that we can deliver a si α-syn to reduce expression of α-
synuclein in a mouse. We recently converted the ribonucleotide backbone of this siRNA to a 2’-MOe anti-sense
oligonucleotide to increase half-life and affinity to the mRNA target. We plan to examine the pharmacokinetics
and toxicology of systemic ApoB11:2’-MOe si α-syn following intra-peritoneal delivery in an α-syn tg mouse
model of DLB. Then we will examine the ability of the ApoB11:2’-MOe si α-syn to reduce α-syn and improve
survival of neurons and improve cognitive ability and motor coordination in an α-syn tg mouse model of DLB.
Finally, we will examine the ability of the ApoB11:2’-MOe si α-syn to reduce the accumulation of α-syn in an in
vitro model of human DLB neurons derived from iPSC cells in a blood-brain barrier model. We believe this may
represent a new method of therapeutic delivery for DLB and other neurological disorders.

Public health relevance
PROJECT NARRATIVE Alzheimer’s disease related disorders (ADRDs) are involved not only the accumulation of amyloid ß and tau but also alpha-synuclein (α-syn). We recently developed a novel peptide for delivery short oligonucleotides across the blood-brain barrier to reduce the expression of proteins such as α-syn. In this proposal we will utilize our expertise in delivering an siRNA against α-syn to the brain to examine the pharmacokinetics and pharmacodynamics of reducing α-syn to determine in models of Dementia with Lewy bodies if this is a viable therapeutic option to move forward for clinical trials.